The Impact of Natural Locomotion on Visual Processing

PROJECT SUMMARY
Vision is a dynamic process, constantly encoding visual stimuli that depend on both one's self motion and the
ever changing visual scene. Past studies have suggested that locomotion modulates visual processing in
numerous brain regions, contributing to modulations of gain, spatial resolution processing, and potentially
attentional state, to name a few. The caveat of many of these investigations is that they were performed in
restrained experimental conditions that limited animals to head-fixation and limited locomotion on a spherical
treadmill. Therefore, the impact of natural, freely moving locomotion on visual processing remains unknown.
We have developed methods to record visual responses during free movement. We will apply this to
investigate how two key visual brain regions, primary visual cortex (V1) and superior colliculus (SC) are
modulated by natural locomotion, and compare two distinct experimental in vivo electrophysiology conditions:
head-fixed and natural locomotion. In Aim 1, I will use in vivo electrophysiology in V1 to analyze visual
responses in both experimental conditions as well as specifically analyzing the impact of locomotion on
suppressed-by-contrast cells. In Aim 2, I will use in vivo electrophysiology in SC to analyze visual responses in
both experimental conditions and compare the locomotor modulation of narrow-field vertical neurons and wide-
field vertical neurons. Together, these aims will determine the impact of natural locomotion on visual
processing in V1 and SC on a global level and at a cell type specific level. The proposed experiments will also
inform future studies aimed at dissecting the neural circuits underlying natural vision and provide experimental
paradigms that may be utilized to study free moving visual neuroscience in a variety of tasks.

Public health relevance
PROJECT NARRATIVE This project will study the impact that natural locomotion has on two key visual areas in the mammalian brain: primary visual cortex and superior colliculus. It will therefore have a direct impact on our understanding of how the visual system functions under natural conditions, thereby contributing to an overall greater understanding of active vision as well as visual impairment.